Translational Pathology Core

PROJECT SUMMARY: TRANSLATIONAL PATHOLOGY SHARED RESOURCE CORE
The Translational Pathology Shared Resource Core (TPSRC) provides collaborative and fee-for service support
to enhance basic and translational research efforts for Meharry Medical College (MMC), Vanderbilt-Ingram
Cancer Center (VICC), and Tennessee State University (TSU) investigators. The TPSRC integrates the Human
Tissue Acquisition, Histology/Immunohistochemical/Histopathology, and Morphology Cores, centrally located at
MMC to provide a comprehensive suite of continually expanding high-quality services including human cancer
research tissue banking and distribution, human and animal tissue processing, sectioning, routine and special
staining, immune-based cell antigen staining, mRNA and DNA in-situ localization, histological and
histopathological review and interpretation, and a variety of state of the art imaging capabilities. The collection
of well-characterized human tissue for correlative research and molecular biology studies is a critical part of
cancer research and is the foundation for the development of effective translational medical research and
personalized molecular diagnostics and treatment. The TPSRC works collaboratively with the research
community and designs, implements, and validates new Core approaches and services. To facilitate integration
with the Biostatistics and Bioinformatics Shared Resource Core, MMC provides an on-campus office for in-house
consultation purposes for investigators who routinely utilize the TPSRC. Our collaboration with the Cancer
Outreach Core in an advocacy and educational role enhances awareness of research efforts to eliminate cancer
disparities in African American and minority groups. The TPSRC will work closely with the Population Research
And Clinical Trials In Cancer Equity (PRACTICE) Shared Resource Core for biospecimen collection. Further the
TPSRC will actively engage with the MVTCP–sponsored research projects proposed by Josiah Ochieng, PhD,
(Project 2) and Anil Shanker, PhD, (Pilot Project) to provide tissues and pathology services to support their
research initiatives.